Project 3

PROJECT 3 - PROJECT SUMMARY
The combination of Immune Checkpoint Blockade (ICB) with the α-PD-L1 antibody atezolizumab, and the
vascular endothelial growth factor (VEGF)-targeting antibody bevacizumab, has become the new FDA
approved Standard of Care (SOC) for advanced Hepatocellular Carcinoma (HCC). However, the 3-year
survival for this SOC is still <30%, leaving a clear unmet need for novel therapies for advanced HCC patients
who have progressed on first-line ICB therapies. Whilst the immune suppressive liver/HCC tumor
microenvironment (TME) restricts the efficacy of anti-tumor T cell responses, the pro-inflammatory nature of
oncolytic virus (OV) infection/replication offers a complementary mechanism of action to ICB by promoting
immune infiltration (immunological heat) into poorly infiltrated (cold) HCC. Our group has conducted a Phase I
first-in-human study of Vesicular Stomatitis Virus (VSV) expressing human interferon beta (hIFN-β) in patients
with advanced sorafenib refractory/intolerant HCC. To investigate how OV could best synergize with ICB to
treat HCC, murine Sleeping Beauty (SB) models of HCC were established in which α-PD-L1 ICB induced 30-
50% long term cures through re-invigoration of specific α-tumor CD8+T populations. However, a combination
of α-PD-L1 ICB with VSV-IFNß to reverse immune suppression in the TME, led to the loss of the survival
benefit of α-PD-L1 alone, associated with replacement of a diverse profile of CD8+ T cell populations in α-PD-
L1-treated tumors with a dominant population of highly activated, α-viral effector CD8+T cells. However, by
expressing an HCC tumor associated antigen (HCCTAA) from VSV, the potent α-viral effector CD8+ T cell
response also became an α-tumor T cell response –with highly activated HCCTAA effector cells becoming
focused on the tumor. In parallel studies, we showed that a novel VSV platform in which the CSDE1 protein is
co-expressed within the virus induced significantly better therapy than the parental VSV-IFNß. Finally, to
enhance infiltration of immune-excluded (cold) HCC with effector α-tumor T cells, we developed novel
nanobody-based CAR T cells specific for the TAAHCC GPC3. In others studies, we have shown that CAR T
cells loaded with oncolytic VSV 1). mediate tumor-specific virus delivery and 2). are significantly more
therapeutically potent than conventional, non-loaded CAR T cells. Therefore, to test our overall hypothesis
that the highly immune suppressive HCC TME, which inhibits endogenous α-HCC T cell responses, can be
reversed in the setting of SOC therapies by administration of appropriately timed and optimally delivered
viro/cellular/immunotherapy, we have formulated 3 Specific Aims: 1: To test how appropriately timed VSV-
CSDE1-TAAHCC virotherapy can optimally enhance SOC immunotherapy in SB models of HCC; 2: To combine
CAR T cell/VSV virotherapy to enhance SOC immunotherapy in murine and human xenograft models of HCC;
and 3: To test the safety of adjuvant VSV-CSDE1-GPC3 virotherapy in a Phase I clinical study as therapy in
patients with advanced HCC who have received SOC bevacizumab/atezolizumab.

Public health relevance
PROJECT 3 - PROJECT NARRATIVE This research project will develop novel regimens by which the current standard of care (SOC) therapy for hepatocellular cancer (HCC) can be enhanced, and extended to patients who have progressed following first- line Immune Checkpoint Blockade (ICB) therapies. We will do this both by using oncolytic viruses expressing tumor antigens associated with HCC (TAAHCC) to direct populations of highly activated effector T cells into the tumor microenvironment (whose anti-tumor cytotoxic activity can be further enhanced by immune checkpoint blocking molecules, such as anti-PD-L1) and by using our novel technology in which oncolytic viruses loaded onto CAR T cells targeting the TAAHCC GPC3 can be used as potent immunological adjuvants to improve the efficacy of CAR T cell therapy against HCC. Finally, as a prelude to testing clinical efficacy, we will test the safety of a completely novel VSV platform as a means of delivering TAAHCC-targeted viro-immunotherapy in a Phase I clinical study of VSV-CSDE1-GPC3 as therapy in patients with advanced HCC who have received SOC bevacizumab/atezolizumab.